Investigating the neuronal function of ZNF185

Project Summary
Intellectual disability (ID) and autism spectrum disorder (ASD) are caused by a wide variety of
environmental and genetic factors. Zinc-finger proteins (ZNF) are among the most abundant proteins expressed
in eukaryotes, are involved in a wide variety of cellular processes. Numerous studies have shown that many ZNF
family members are linked to neurologic disorders, including ID and ASD. ZNF185 is a member of this family,
comprised of an actin filament-binding domain and a single zinc-finger containing LIM domain. ZNF185 has been
suggested to act as a tumor suppressor gene, but it is otherwise an understudied protein with no known function
in the nervous system. Our preliminary data indicate that ZNF185 is highly expressed in the adult hippocampus,
and it is enriched in the presynaptic compartment of excitatory synapses. We hypothesize that ZNF185 regulates
synaptic function, and that its disruption could lead to impaired cognition and autistic behaviors. To test this
hypothesis, we will use a recently developed ZNF185 knockout mouse model. In the first aim, we will use super-
resolution imaging and acute slice electrophysiology to examine the role of ZNF185 in synaptic development
and function. In the second aim, we will examine the effects of ZNF185 knockout on brain development and
behavior. The successful completion of this proposal will determine how ZNF185 regulates neural development,
synaptic function, and behavior, with important implications for our understanding of neurologic disorders such
as ID and ASD.

Public health relevance
Project Narrative Approximately 3% of Americans are estimated to have an intellectual disability (ID), and 2% of American adults are thought to have autism spectrum disorder (ASD). ID and ASD can be caused by a wide array of genetic factors, including mutations in the zinc finger (ZNF) family of proteins. The goal of this study is to investigate the molecular and cellular functions of ZNF185 using a newly generated knockout mouse model, thereby improving our understanding of the mechanisms underlying ID and ASD.